Maternal control of germline development

Abstract
Primordial germ cells (PGCs) are the precursors of the gametes. Defective PGC development results in
reduction or elimination of germ cells and ultimately causes infertility in humans, which affects 10–15% of
couples. During development, PGCs are born much earlier than the formation of the gonads. PGCs must
manage to survive in the non-protective somatic environment for a long time and later migrate long
distances to find the gonads. Specification of PGCs and their proliferation during early stages are crucial
to ensure that sufficient number of PGCs can reach the gonads and differentiate into gametes. A large
body of literature has demonstrated that before migrating into the gonads, PGC development relies heavily
on translational and post-translational regulatory mechanisms. Understanding how PGC development is
operated at the translational and post-translation levels thus is highly relevant to human reproductive
health. My laboratory studies early PGC development using Xenopus as a model. We recently reported
that maternal Dead End1 (Dnd1) is important for asymmetric localization of mRNA in the oocyte. After
fertilization, Dnd1 recruits the translational machinery to nanos mRNA and promotes nanos translation.
Through this mechanism, Dnd1 prevents somatic differentiation of PGCs and protects their totipotency.
Our recent preliminary results reveal that Dnd1 is rapidly degraded in the oocyte by the ubiquitin-
independent proteasome system. In order for Dnd1 to accumulate and promote nanos translation after
fertilization, RNAs coding for proteasome activators must be separated from dnd1 and other germline
specific maternal factors during the oocyte-to-embryo transition. We propose to study how this novel
mRNA translocation event prepares for the initiation of PGC development after fertilization and investigate
how RNAs coding for proteasome activators are separated from dnd1 and other germline specific maternal
factors during the oocyte-to-embryo transition. Moreover, we have made an exciting finding that the first
wave of PGC proliferation is regulated by maternal Dzip1. We will determine if Dzip1 regulates PGC
proliferation via binding and modifying the activities of germline specific RNA-binding proteins.
Furthermore, we will identify the zygotic transcriptional network that acts downstream of Dzip1 to control
PGC proliferation. These works will make important contributions to our understanding of basic cell,
reproductive, and developmental biology.

Public health relevance
Project Narrative: Since human infertility affects 10–15% of couples, a better understanding of the development of primordial germ cells (PGCs), which give rise to sperms and eggs, is highly relevant to human reproductive health. We study how PGC development is initiated and how PGCs proliferate during early stages. Findings from our research will advance the knowledge on stem cell, developmental, and reproductive biology.